High Performance, Highly Deployable Head-Only MRI Scanner

DESCRIPTION (provided by applicant): The motivation for the proposed program is the realization that the current multi-use whole-body MRI scanners limit optimal neuroimaging. Current scanners are based on the one-size-fits-all concept of whole-body imaging and do not have the full range of functionalities that could be achieved in a scanner designed to image only the brain. GE Global Research and the Mayo Clinic propose to jointly develop and validate a radically new MR system optimized for neuroimaging. This system is based on a revolutionary lightweight magnet, gradient and RF design to permit high quality 3T MRI of the human brain. This new scanner will provide much greater patient comfort, markedly improved image quality, and much higher performance in terms of speed and range of imaging capabilities such as gradient strength and slew rate. In addition, the significant reduction in size and weight will allow the placement of the scanner in locations that are currently inaccessible to whole-body MRI scanners. This program will develop: 1) Enabling cryogen-free magnet and gradient technologies include advanced cryogenic and magnet design, head-only high-performance gradients, an RF coil with integrated fMRI simulation capabilities, and optimized patient ergonomics. 2) A high-performance prototype 3T head-only imaging system, that will be evaluated on human volunteers. 3) Optimized image acquisition protocols and image analysis technology to permit improved assessment of brain disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Global Research and the Mayo Clinic propose to develop a new concept MRI brain scanner that is both lightweight and high performance. This scanner represents a 10 times reduction in weight and can be placed in locations that are easily accessible to patients. Successful implementation of this idea will allow greater availability of advanced neuroimaging to meet a range of neurological and psychiatric disorders, such as depression, autism, traumatic brain injury, and stroke. PROJECT NARRATIVE GE Global Research and the Mayo Clinic propose to develop a new concept MRI brain scanner that is both light weight and high performance. This scanner represents a 10 times reduction in weight and can be placed in loca- tions that are easily accessible to patients. Successful implementation of this idea will allow greater availability of advanced neuroimaging to meet a range of neurological and psychiatric disorders, such as depression, au- tism, traumatic brain injury, and stroke. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The following sections marked with an asterisk (*) contain proprietary/privileged information that GE Global Research and Mayo Clinic requests not be released to persons outside the Government, except for pur- poses of review and evaluation. GE Global Research in Niskayuna, NY, in close collaboration with clinical researchers at the Mayo Clinic in Rochester, MN, proposes to build and validate a radically redesigned head-only magnetic resonance (MR) sys- tem optimized for use in the management of brain diseases and injuries. The proposed head-only system will be designed with closed-loop heat-pipe cooling operating at 4.2K and thermal storage ("cryogen-free" operation). It will feature the ability to survive power outages and will incorporate low eddy current superconductor and cryostat components, an unshielded (or partially shielded) head gradient coil, and radio frequency (RF) head coils. It will also feature integrated functional magnetic resonance imaging (fMRI) stimulation capabilities and optimized patient ergonomics. The team will also begin to develop optimized imaging techniques and post-pro- cessing procedures to demonstrate the ability of this scanner to provide useful quantitative information unavail- able from current scanners. It is expected that these quantitative techniques will be tested and refined in future clinical research based on the new head-only 3T MR system prototype to be developed in this project. The Mayo Clinic Department of Radiology, GE Global Research, and the GE Healthcare business have a long-term and highly successful relationship in MR imaging research. In the proposed program, a prototype head-only 3T MRI system will be developed using cutting-edge magnet technologies. The proposed NIH invest- ment will be amplified by related GE investments in high-field magnet design and superconductor technology, which constitute one component of GE's in-kind contributions. The BRP format provides for a greatly beneficial interaction of leading clinical scientists with industrial scientists involved with optimizing scanner hardware. By closely involving the collaborators from Mayo Clinic in the early stages of requirement specification for scanner development, the ergonomic aspects of patient comfort and clinician accessibility will be designed into the sys- tem at an early stage. This involves the active participation of both GE and Mayo Clinic investigators in decisions involving engineering trade-offs. Two major features of this scanner are expected to have major impact on the clinical utilization of brain MRI. Greatly improved gradient performance, because of the small size gradients compared to those used in whole- body scanners, will lead to shorter acquisition times and improved image quality. Because of the low stored en- ergy and low inductance of these coils, a markedly increased gradient field strength and slew rate can be at- tained compared to whole-body gradient systems, while dramatically reducing the gradient power supply re- quirements. The smaller coil size will also lead to a decrease in peripheral nerve stimulation as less of the body is exposed to the gradient fields and smaller gradient current densities are required to achieve a given gradient strength. The second major feature is the remarkably light weight of the scanner. This will permit installation on upper floors of hospitals and it will also facilitate non-traditional but convenient location in free-standing clin- ics, emergency rooms, and mobile facilities providing MRI services to rural populations. In addition, there are possible applications to military medicine by providing high-quality MR neuroimaging diagnostic capabilities closer to the combat theater of operations. Aim 1-Develop lightweight magnet technology to enable head-only 3T MRI. (Years 1-2) Develop technology for a revolutionary lightweight magnet, gradient and RF system to permit high quality 3T MRI of the human brain. This new scanner will provide much greater patient comfort, markedly improved im- age quality, and much higher performance in terms of speed and range of imaging capabilities, such as gradient strength and slew rate. There will also be a much improved patient accessibility and flexibility for performing sensory stimulation in functional MRI. A key goal is to optimize the ergonomic aspects of the positioning of the patient during the scan to achieve maximum patient comfort with much less confinement than in conventional MR scanners. Develop system specifications for a magnet capable of operating at 4.2K and tolerant to power outages. A flow-down of these specifications to the component level will be performed. Magnet specifications are ultimately driven by system-level specifications including field of view (FOV), uniformity, and site-ability so that the final product has high clinical relevance. Enabling magnet technologies will be developed to meet these specifica- tions, such as closed-loop heat-pipe-cooling, thermal storage, low-eddy current superconductor, and cryostat components. A mock-up testbed will be developed, along with head-only high-performance unshielded or par- tially shielded gradient coils and high performance RF coils. Optimized patient ergonomics will be developed. Aim 2-Fabricate components and integrate them into a prototype system. (Years 2-4.5) Design, build, and test the 3T head only magnet, gradient, and RF coil. Integrate the magnet and the gradient system with necessary peripheral components to produce a complete, high-performance prototype 3T head-only imaging system. The performance of the 3T head-only imaging system will be evaluated by both GE and Mayo Clinic investigators against its specifications using standard procedures. In addition, specific ergonomic, gradi- ent coil, and eddy-current procedures novel to this system will be developed. Aim 3-Evaluate clinical performance of the head-only imaging system. (Years 1-5) Conduct ergonomic tests on the mock-up test bed device at GE Research in years 1 & 2 in consultation with Mayo Clinic. Continue evaluation of system performance on phantoms and human volunteers at GE Research in years 3-4.5. In years 4.5-5, the prototype scanner will be sited at the Mayo Clinic in Rochester, MN for the pur- pose of clinical feasibility testing. Compare the performance of the optimized head-only system to that of a high- performance whole-body 3T MRI scanner using both phantoms and healthy human volunteers and volunteer patients under an IRB-approved protocol. Also, the high-performance gradient capabilities of the lightweight 3T system will be exploited for protocol optimization, including customized pulse sequence programming.